microRNA regulation of NMNAT-mediated Neuroprotection against Peripheral Neuropathy and Chronic Pain

PROJECT SUMMARY
Peripheral neuropathy and neuropathy pain can be caused by a myriad of genetic and environment
factors as well as therapeutic or recreational drug use. In particular, chemotherapy-induced peripheral
neuropathy (CIPN) is the major dose-limiting neurotoxic side effect of standard chemotherapy regiments. Over
68% of cancer patients experience neuropathic symptoms after chemotherapy, and that contributes to a
significant percent of the population that suffer from chronic pain and have to resort to opioid use. Currently there
are no effective treatments available, largely due to a lack of understanding of the in vivo mechanisms of CIPN
and related peripheral neuropathy. Recently, we have optimized a model of peripheral neuropathy using
Drosophila larvae that recapitulates salient behavioral, physiological, and cellular aspects of chemotherapy-
induced sensory dysfunction. Our preliminary work using this model has uncovered a new mechanism underlying
peripheral neuropathy and identified a neuroprotective protein NMNAT with promising potential for mitigating
neuropathic pain. The ultimate goal of our research is to uncover the endogenous mechanisms underlying
peripheral neuropathy and to identify neuroprotective mechanisms and potential targets that facilitate the
development of new therapeutic agents against CIPN and related neuropathic pain.
Extensive mechanistic studies from our lab and others have found NMNAT proteins in Drosophila and
mammals to be among the most robust and versatile neuroprotective factors, and a positive correlation between
NMNAT expression levels and the neuronal self-protective capacity. Excitingly, from a compound screen, several
natural compounds were identified to upregulate NMNAT transcription, and we have collected intriguing
preliminary results suggesting that the expression of NMNAT is regulated by microRNAs. We hypothesize that
regulation of NMNAT RNA expression by natural compounds and microRNAs at the steps of transcription, pre-
mRNA splicing, and mRNA stability allows rapid and dynamic shifting between NMNAT mediated NAD+
metabolism and neuronal resilience and confers protection in sensory neurons against peripheral neuropathy.
In this application we outline experiments to (1) identify microRNAs that regulate nociceptive hypersensitivity,
(2) identify and characterize the molecular pharmacology of natural compounds in regulating NMNAT
expression, and (3) modulate NMNAT transcriptional regulation to enhance neuroprotection against peripheral
neuropathy. The objectives for the supplement application are to expand our testing portfolio to include 12
microRNAs and 24 natural compounds. With the recruitment of a full graduate student effort, we will be able to
expand our candidate screening portfolio by > 80% and will significantly increase the likelihood of success in
identifying candidates with high neuroprotective potential. In addition to the scientific goals, this diversity
supplement will also support the PhD training in novel natural compound discovery for pain and fulfill the career
development goals of Ms. Natalie Ortiz Vega in the field of natural compound pharmacology.

Public health relevance
PROJECT NARRATIVE Neuropathic pain is a serious and long-term neurotoxic side effect of chemotherapy affecting more than 68% of cancer patients, and is currently without treatment. Our studies on sensory neuronal maintenance have found NMNAT proteins to be among the most robust and versatile neuroprotective factors known and have the potential to mitigate sensory dysfunction. The proposed studies will employ innovative technologies to discover microRNA and neutral compound-based neuroprotective strategies to enhance NMNAT-mediated therapeutic treatments for neuropathic pain.